PHARMACOKINETICS AND PHARMACODYNAMICS OF ONCE DAILY AMINOGLYCOSIDES

Available adult and limited pediatric data suggest that aminoglycoside agents may be safer and more effective when administered just once daily. This study will be a prospective, controlled, randomized trial comparing once-daily gentamicin to traditional gentamicin regimens in pediatric patients. Efficacy will be evaluated by documenting clinical course and microbiological cure/eradication. Safety will be evaluated by monitoring for changes in renal function, aminoglycoglycoside serum concentrations, and pre/post auditory exams.